Identification of genes that limit CAR T persistence in solid tumors

Project Summary
Chimeric Antigen Receptor T (CAR T) cell therapy has been highly effective in a subset of hematological
malignancies. However, this efficacy has not translated to solid tumors for a variety of reasons, including limited
persistence in an immunosuppressive and metabolically challenging tumor microenvironment. Unbiased
techniques such as genome-scale CRISPR screens have identified several pathways to enhance therapeutic
efficacy. However, these screens have mainly utilized reductionist in vitro approaches, and do not recapture a
solid tumor microenvironment. I have performed a genome-wide in vivo CRISPR screen of human CAR T
persistence in solid tumors. The top two hits were ATXN7L3 and USP22, components of the Spt-Ada-Gcn5
acetyltransferase (SAGA) complex deubiquitylation module (DUB). The SAGA DUB is primarily known for its
role in histone H2B deubiquitination, but its role in T cell persistence and antitumor function remains to be
described. I show knockout of USP22 or ATXN7L3 (USPKO/ATXKO) increased T cell memory markers and
enhanced CAR T expansion and persistence in vitro. Paradoxically, USPKO/ATXKO CAR T exhibit a defect in IL-
2 secretion and fail to enhance antitumor immunity or persistence in vivo. The data indicate that USP22 and
ATXN7L3 are fundamental regulators of CAR T cell function, yet the mechanisms through which they influence
CAR T biology remain unclear. I hypothesize that knockout of USP22 or ATXN7L3 reprograms the CAR T
transcriptome through changes in histone ubiquitination and augments CAR T persistence in an IL-2 dependent
manner. In Aim 1, I propose to determine the relationship between cell-extrinsic IL-2 and USPKO/ATXKO CAR T
persistence in solid tumors. I postulate that cell-extrinsic IL-2 is sufficient to rescue USPKO/ATXKO persistence
and enhance antitumor activity. As USPKO/ATXKO CAR T persist in a pooled in vivo setting, I will pool wildtype
CAR T cells with USPKO/ATXKO CAR T at different ratios and infuse into tumor-bearing mice to assess
persistence and antitumor activity. I will also determine the effects of exogenous IL-2 supplementation on in vivo
USPKO/ATXKO CAR T persistence through serial recombinant IL-2 infusions. In Aim 2, I propose to investigate
the impact of USPKO/ATXKO and histone deubiquitination on CAR T transcriptional programs. I hypothesize that
H2B deubiquitination through SAGA regulates gene expression programs that promote CAR T persistence. To
evaluate this, I will perform bulk RNA-sequencing and histone ubiquitin CUT&RUN-sequencing on USPKO/ATXKO
to determine the extent to which histone ubiquitin changes affect these programs. Together, the findings of this
work will describe a novel role for the SAGA complex and histone ubiquitination in CAR T persistence and has
potential for direct clinical translation for treatment of solid tumors.

Public health relevance
Project Narrative CAR T cell therapy has failed to translate to solid tumors, partly due to limited intratumoral persistence of CAR T cells. The proposed work builds upon the first in vivo genome-scale CRISPR screen of CAR T persistence in solid tumors and will investigate ATXN7L3 and USP22 in regulating this process. This work will provide further knowledge on engineered T cell biology and its findings have the potential for direct clinical translation to enhance CAR T cell therapy.